Research Capacity Core

PROJECT SUMMARY / ABSTRACT
A team-science approach is vital in biomedical research, given the heightened competition for extramural
research dollars, leading investigators to increasingly rely on technical cores for expertise to meet their research
needs. Modern core facilities must also evolve and adapt their resources and capabilities to support scientists
from wide-ranging disciplines and develop business plans to become more sustainable. The Ola HAWAII
Research Capacity Core (RCC) was strategically designed to meet these challenges. The objective of the RCC
is to enhance the quality and productivity of health disparities and health-related research through
world-class research facilities and services. The RCC will work closely with the Community Engagement
Core (CEC) and Investigator Development Core (IDC), as well as the Administrative Core (AC), to directly
support the Ola HAWAII research projects and pilot projects, as well as provide exceptional resources and
services to the larger research community. The RCC will be structured with six support facilities for Data
Science, Biostatistics, Behavioral Research, Clinical Research, Histopathology, and Regulation and Compliance.
Support for research methodology and personalized mentoring will be provided through an innovative Research
Studio Program and support for community engagement will be provided through collaborations with the CEC.
Specific Aim 1: Strengthen and sustain core facilities and resources.
a. Establish policies and procedures for management and prioritization.
b. Cultivate diverse revenue streams and leverage institutional commitments for sustainability.
c. Track and evaluate user satisfaction and quality and effectiveness of core services.
Specific Aim 2: Expand and diversify core user base, capacity, and reach.
a. Market core resources, services, and expertise.
b. Conduct needs assessments for development of new tools and services.
c. Expand user access to other support facilities.
Specific Aim 3: Implement a personalized Research Studio Program.
a. Market and promote the Research Studio Program.
b. Identify and engage faculty to serve as subject-matter experts.
c. Track and evaluate effectiveness of the Research Studio Program.
To execute our action plan, the RCC has assembled an exceptional leadership team with deep research
experience and technical expertise and has garnered broad institutional and community support. Successful
completion of these Aims will greatly enhance the quality and productivity of research in Hawaii seeking to
advance minority health and decrease health disparities, and increase both the competitiveness and diversity
of our biomedical research workforce.